Data Management and Statistics Core

Project Summary - Data Management and Statistics Core (Data Core)
The Data Management and Statistics Core (Data Core or DC) for the Indiana Alzheimer’s
Disease Research Center (IADRC) is the central repository for data collected by all IADRC
cores. The DC maintains an advanced integrated data management system with electronic data
capture and real-time data visualization for the daily functioning of all IADRC cores and for
contributing data to collaborative research initiatives. DC members provide crucial statistical and
data management support to all research activities conducted by the multidisciplinary IADRC
investigator team. For this renewal, the DC will expand the capabilities of the web based IADRC
Data Hub by developing additional real-time dashboard functions and new data capturing tools
for new IADRC operation and program evaluation. The DC will continue to submit the Uniform
Data Set (UDS), neuropathology, neuroimaging and biomarker data to the National Alzheimer’s
Coordinating Center (NACC) on a regular basis and provide data to other national collaborative
studies. The DC will provide statistical and bioinformatic leadership to IADRC investigators in
AD related dementia (ADRD) research and core members will also conduct independent
statistical/bioinformatic research. In addition, the DC will provide training and mentoring in
statistical/bioinformatic methods to junior faculty, research fellows, and Ph.D. students in AD
related research. The DC will ensure cooperation, concurrence and collaboration from the initial
specification of data content to database management and data analysis, thereby enhancing the
IADRC’s capacities in the fight against ADRD.